Cellular Anatomy of Tau Seeding

Project Summary/Abstract:
The propagation of tau pathology along synaptically connected brain circuits is considered a
major driver of cognitive decline in Alzheimer’s Disease (AD). However, the mechanisms underlying
proteopathic tau seed entry and amplification within human neurons remain unclear. Given the putative
role of brain circuits in tau propagation, axons/axon terminals or dendrites may be involved in tau seed
uptake. However, this has never been determined in neuronal models, and typical methods to study
these events, such as light microscopy and immunofluorescence alone, have critical resolution limits.
Thus, we cannot yet hypothesize where in a neuron that the tau seeds access the cytoplasm and
replicate. To answer these questions, we will apply high-resolution correlative light and electron
microscopic imaging (3D-CLEM), combined with advanced cell-based fluorescent biosensors and novel
conformational antibodies with live cell imaging in human neurons derived from inducible pluripotent
stem cells (iPSCs) available here in our center. Our strategy should enable determining where tau seed
uptake occurs, and the localization and sub-cellular components and/or molecular machinery involved
in tau seed amplification, while bypassing protein aggregate extraction techniques that introduce
experimental artifact. By exploring these mechanisms using high-resolution correlative imaging within
human neurons, we will address how proteopathic seeds access the cytoplasm and replicate, which
may have broader implications for other related neurodegenerative diseases.

Public health relevance
Project Narrative: Tau pathology accumulates in a progressive pattern that is consistent with propagation along synaptically connected brain circuits. However, it is unknown how they enter neurons and replicate. I propose to use 3D correlative light and electron microscopy combined with fluorescent biosensor systems and novel conformational tau antibodies in human neurons to test how tau seeds access the cytoplasm, and with which cellular sub-components they amplify.